All of Us Research Program Engagement and Retention Innovators

Research. We will begin by reviewing the existing digital experiences and conducting a gap
analysis before quickly moving into conducting research with potential and existing AoURP
participants to identify engagement priorities from the perspective of each audience.

Design. Grounded in co-creation, digital experiences will be developed through collaborative and iterative inputs from key parties across the AoURP Network. Depending on the audience, co-creation and testing may be conducted in-person and/or virtually with community advisory groups in collaboration with community-based organizations (CBOs), through targeted recruitment, and/or through an online research platform. As an example, Alexandra Bornkessel, proposed Task 4 lead, led the creation of an online research panel for an Administration for Children & Families national youth health campaign using the CMNTY platform for 120+ youth from over 26 U.S. states.

Public health relevance
The All of Us Research Program is a historical effort to develop a large, longitudinal dataset designed to accelerate health research and discoveries that will enable personalized prevention and treatment for everyone. Its governance model encourages transparency and engagement of participants and researchers. This active engagement will increase trust and the potential for significant public health impact.